Clinical Validation of a Point-of-Care Precision Medicine Endotyping Platform

Principal Investigator/Program Director (Last, first, middle): Reddy, Jr., Bobby
Project Summary:
Sepsis is a devastating and highly heterogeneous diseases that each encompass a wide range of etiologies,
sites of infections, and a wide spectrum of pathophysiologic and biologic manifestations. This heterogeneity is a
critical problem for the development of novel therapeutics.
Prenosis has pioneered a biomarker-based, machine learning approach to endotype classification for
characterizing host response to infection and deconvoluting disease heterogeneity. Endotypes are subgroups of
patients with similar biologic processes or states, and the fields of sepsis and ARDS have identified biological
endotyping as the leading approach to overcome the challenges heterogeneity poses to patient care and
therapeutic development in acute care. The Prenosis host response maps and endotypes are built on the
proprietary NOSIS dataset/biobank, which links clinical data to 91,000+ biospecimens from over 23,000 infection
patients at 10 U.S. hospital sites. Patient plasma samples are assayed for 43 protein biomarkers and combined
with clinical measurements (labs, vitals, etc.) extracted from patient EMRs using sophisticated AI to construct
precision medicine maps that summarize patient pathophysiology at a particular moment in time.
The Immunix platform brings together clinical data, novel host response biomarkers, and AI-enabled precision
medicine tools in real time at the point of care. This combination is tremendously innovative. This is the approach
that researchers and Key Opinion Leaders in sepsis and ARDS have been clamoring for and working toward. It
is unquestionably an important step forward for the field, and it is no exaggeration to claim it has the potential to
change the way clinical trials are run in acute care. Every component of this platform is complete and validated.
This project is the final step in demonstrating the capabilities of the entire Immunix platform.
The overall hypothesis of the current project is that the Prenosis Immunix platform, which includes the
ImmunoScan Multiplex Rapid Test, can deploy precision medicine patient stratification solutions to the point of
care in real time. The overall goal is to leverage the NOSIS biobank, Prenosis’ existing biomarker testing pipeline,
and our network of hospital sites to validate ImmunoScan immunoassays and generate mapping functions to
Luminex Immunoassays (Aim 1); validate a parsimonious model for point-of-care endotyping (Aim 2); and
demonstrate in a prospective study the ability of Immunix to classify patients into host response endotypes in
real time at the point of care (Aim 3). Successful completion of this project will show that the Immunix platform
is fully capable of patient stratification and set the stage for running precision medicine clinical trials in acute
care, a prospect whose innovation and significance cannot be overstated.

Public health relevance
Principal Investigator/Program Director (Last, first, middle): Reddy, Jr., Bobby Project Narrative: The overall hypothesis of the current project is that the Prenosis Immunix platform, which includes the ImmunoScan Multiplex Rapid Test, can deploy precision medicine patient stratification solutions to the point of care in real time. The overall goal is to leverage the NOSIS biobank, Prenosis’ existing biomarker testing pipeline, and our network of hospital sites to validate ImmunoScan immunoassays and generate mapping functions to Luminex Immunoassays (Aim 1); validate a parsimonious model for point-of-care endotyping (Aim 2); and demonstrate in a prospective study the ability of Immunix to classify patients into host response endotypes in real time at the point of care (Aim 3). Successful completion of this project will show that the Immunix platform is fully capable of patient stratification and set the stage for running precision medicine clinical trials in acute care, a prospect whose innovation and significance cannot be overstated.